Advancing the development of a novel class of small molecules for treating pan-coronavirus infections

Abstract
For the past decade, our laboratory has been studying the role of cellular kinases in intracellular trafficking of
RNA viruses and as targets for broad-spectrum antivirals. Furthermore, we have provided a proof of concept
for the potential feasibility of the host-targeted broad-spectrum antiviral approach by demonstrating that the
inhibition of two cellular kinases, AAK1 and GAK, by novel or the approved anticancer drugs, sunitinib and
erlotinib, protects mice from dengue and Ebola viruses with a high barrier to resistance. Since the therapeutic
index (TI) of this drug combination is narrower for SARS-CoV-2 infection, here, we focus on an independent
class of compounds, the isothiazolo[4,3-b]pyridine-based RMC-113 series, that emerged from our prior work,
but does not inhibit AAK1 or GAK. We showed that RMC-113 and 25 related analogs have potent broad-
spectrum antiviral activity with a high barrier to resistance. Excitingly, RMC-113 reduces SARS-CoV-2 titer to
undetectable levels at non-toxic concentrations and binds PIKFYVE, a cell kinase that regulates endosomal
trafficking. We hypothesize that RMC-113 analogs inhibit both multiple distinct steps in the SARS-CoV-2 life
cycle and the inflammatory response to this virus, in part by targeting PIKFYVE, thereby offering attractive and
safe candidate inhibitors to combat SARS-CoV-2, other pandemic coronaviruses and other emerging viruses.
In Aim 1, we will use a multi-dimensional medicinal chemistry approach to optimize the TI and PK profile of
lead RMC-113 analogs and define their in vitro therapeutic potential as broad anticoronavirus inhibitors. Aim 2
will determine the effect of prioritized analogs and apilimod, a repurposed drug candidate for COVID-19 that
inhibits PIKFYVE, on viral replication, cytokine response and tissue injury in organoids derived from excised
normal lung tissue supplemented with PBMCs from 20 human donors and in two rodent models. Aim 3 will
generate ADME-toxicity and safety pharmacology datasets to select pre-IND candidates. In Aim 4, we will
probe the mechanism of antiviral action of RMC-113. We will validate PIKFYVE as a candidate target and use
an unbiased CRISPRi screen to identify RMC-113’s target(s) and profile its chemical-genetic landscape. In
parallel, we will design a clickable RMC-113 probe to confirm the molecular target via activity-based protein
profiling and to monitor target engagement. Lastly, we will probe functional relevance and specific roles of
PIKFYVE and other candidates emerging via these approaches in SARS-CoV-2 infection, and validate them as
the molecular target(s) mediating the antiviral effect. The predicted immediate impact is that this project will
provide insight into the therapeutic potential and MOA of apilimod, a repurposed drug candidate (beyond the
reported effect on viral entry), and will establish a unique human lung organoid model for studying SARS-CoV-
2 pathogenesis and response to treatment under more natural conditions. In the longer term, successful
completion of our study will deliver a drug-like small molecule candidate designed to protect against resurge of
COVID-19 and to provide readiness for future outbreaks with coronaviruses and other emerging viruses.

Public health relevance
Project narrative Off label use of existing drugs may offer protection, yet to date, the repurposed approaches studied for COVID- 19 treatment have demonstrated only modest utility and some have increased morbidity and mortality due to serious side effects. We have discovered a novel class of compounds that targets a host function and effectively suppresses replication of SARS-CoV-2 (severe acute respiratory syndrome coronavirus 2) and other emerging viruses. We will optimize these compounds, determine their therapeutic potential and decipher their mechanism of antiviral action, thereby advancing the development of a class of antivirals that can provide readiness for resurge of COVID-19 and future outbreaks with coronaviruses and other newly emerging viruses.